Single Cell Analysis of HIV-1 Latent reservoir establishment in Humanized Mice

Abstract
Human Immunodeficiency Virus (HIV) has infected 76 million people worldwide and caused the death of 38
million. Current treatments can reduce patient viral loads but fail to cure patients of infection. This is due to the
ability of the virus to undergo latency during antiretroviral therapy. Latently infected cells are nearly
indistinguishable from uninfected cells and there is no effective treatment to eliminate these cells. Our long-
term goal is to describe at a single cell level, how early reservoir seeding occurs and the mechanisms that
drive latency establishment. The proposed experiments in this grant are based on the hypothesis that during
acute infection, a proportion of infected CD4+ T cells from diverse lineages of T cells such as resting CD4+
memory, activated T cells, naïve T cell, effector memory T cell undergo early latency and that transcriptional
pathways such as mTOR and EIF2 signaling and provirus integration into transcriptionally repressive site are
mechanisms of early latency establishment. This hypothesis is based on observations that: i) despite extremely
early ART treatment, HIV latent reservoir may be established earlier than 72 hours after exposure ii) a diverse
subset of T cells can harbor latent HIV iii) complex interactions between host and viral factors drive latency.
First generation latency marking technology has been developed by the Chen lab to report the history of HIV
infection through irreversible marking all HIV-infected cells called HIV-Induced Lineage Tracing (HILT). In this
application, I propose a second-generation, innovative genetic marking technology, Enhanced HILT (EHILT), to
further our knowledge the complexities of HIV latency. Using EHILT and validated small animal models of
latency, I will define early latency kinetics in in vitro and in vivo acute and ART-treated infection using EHILT,
identify transcriptional profiles and pathways associated with latency in vivo, and profile the integration sites of
provirus with immediate latent phenotype.

Public health relevance
Project Narrative Human Immunodeficiency Virus (HIV) has infected 76 million people since the beginning of the epidemic and current treatments fail to cure patients of infection due to the ability of the virus to undergo latency during antiretroviral therapy. This study will identify the cell types that make up the early latent reservoir, the transcriptional states that support latency and the integration sites of latently infected cells in peripheral blood and lymphoid tissue. Understanding the mechanisms that regulate HIV latency during acute infection will allow us to better target the latent reservoir, bringing the field closer to finding a cure for HIV.